Mechanistic characterization of vaginal microbiome-metabolome associations and metabolite-mediated host inflammation

Project Summary/Abstract
The vaginal microbiome is associated with important health outcomes, including bacterial vaginosis (BV),
preterm birth, HIV risk, and cervical cancer, but mechanisms for these associations are unclear and current
microbiome-directed therapies have low efficacy. Metabolome alterations including high-level production of
amines like putrescine are a defining feature of BV and a major cause of symptoms, but underlying mechanisms
and host responses to BV-associated metabolites including amines are poorly characterized. In preliminary data
from a South African cohort with high BV prevalence, 60% of detectable metabolites in vaginal fluid significantly
differ between optimal Lactobacillus-dominant bacterial communities and non-optimal non-Lactobacillus-
dominant (NLD) communities. Strongly BV- and NLD-associated metabolites included putrescine and imidazole
propionate (ImP), both of which are known to have adverse host effects in non-vaginal diseases but whose
production and effects remain largely uncharacterized in the genital tract. These results suggest bacteria
comprising NLD communities express enzymes that produce these metabolites. The study will (1) characterize
metabolome and metagenome composition in additional cohorts to validate findings and identify candidate
enzymes for putrescine and ImP production, (2) characterize the enzymes in cultured vaginal bacteria and
assess effects of known pharmacologic inhibitors, and (3) assess effects of putrescine and ImP on metabolic
and inflammatory host responses and test whether they can be blocked by known host pathway inhibitors. The
results will elucidate vaginal metabolome-related pathophysiology and may directly identify candidate therapies.
The PI is an Instructor in Medicine at Harvard Medical School and the Division of Infectious Diseases at
Massachusetts General Hospital (MGH); in addition to the research plan this proposal includes a five-year career
development plan. His career goal is to become an independent physician-scientist investigator studying
mechanisms of vaginal microbiome- and metabolome-mediated disease through bacteriologic, biochemical, and
immunologic approaches to identify novel therapies. The proposal builds on the PI’s prior experience studying
vaginal microbiome dynamics and investigating the physiology of bacterial species within the microbiome. The
current proposal significantly expands his scientific scope by investigating microbial determinants of vaginal
metabolome composition, identifying host pathways those metabolites affect, and testing pathway inhibitors. He
will pursue this research under the guidance of his primary mentor, Dr. Doug Kwon, at the Ragon Institute of
MGH, MIT and Harvard and his co-mentor, Dr. Emily Balskus, at the Harvard University Department of Chemistry
and Chemical Biology. He will pursue didactic coursework and receive training, guidance, and collaboration from
a diverse team of experts. The proposed training provides the PI with a unique skillset and wealth of initial data
to facilitate his transition to research independence.

Public health relevance
Project Narrative The vaginal microbiome is linked to important health conditions including bacterial vaginosis (BV), preterm birth, HIV, and cervical cancer, but reasons for these links are unclear and current BV-directed therapies do not work well. We will study how metabolites in vaginal fluid, including the potentially harmful molecules putrescine and imidazole propionate, are produced by the microbiome, how they cause inflammation in the vagina, and whether they can be blocked by pharmacological agents. The results will provide important new knowledge about causes of BV and vaginal diseases and will help to find new therapies for preventing and treating these diseases in women globally.